How Does Normalization Regulate Visual Competition?

PROJECT SUMMARY/ABSTRACT
How does the human visual system regulate competing sensory information? Prevailing theories propose that
a computation known as divisive normalization plays a key role in governing neural competition. Normalization
is considered a canonical neural computation, potentially driving responses throughout the brain. Interestingly,
there is evidence to suggest that normalization’s pervasive role relies on an exquisite tuning to stimulus
features, such as orientation and spatial frequency, but this feature-selective nature of normalization is
surprisingly understudied, particularly in humans. Our long-term goal is to understand the neural mechanisms
supporting vision across the visual hierarchy in humans, and to characterize how they flexibly change with
selective attention. The aim of this proposal is to employ state-of-the-art functional neuroimaging techniques
and analyses to shed light on the tuning characteristics that allow normalization to control population
responses within human visual cortex, and to understand how normalization can support selective attention.
We approach the problem by first characterizing the selective properties of normalization within early visual
cortex during normal, passive, scene viewing. We will then assess the unifying potential of models based on
divisive normalization, examining the role that normalization plays in regulating competition via spatially-
directed and feature-based attention. By revealing the role played by tuned normalization within human visual
cortex, these studies will provide the necessary framework for the development of diagnostic tools and
treatments for clinical disorders that involve deficits in central visual processing.

Public health relevance
PROJECT NARRATIVE This project will investigate how inhibitory and excitatory neural computations influence basic responses in human visual cortex, as well as how these computations work in concert with attention to selectively enhance perception. The results will inform models of the human visual system, which provide a necessary framework for the development of diagnostic tools and treatments for clinical disorders that involve deficits of central visual processing. Moreover, the studies of visual attention will further inform the development of diagnostic tests and interventions for attention-related disorders.